Modeling epithelial morphogenesis in the Drosophila eye

PROJECT SUMMARY/ABSTRACT
Many epithelial tissues are characterized by collections of cells with specific shapes and functions that are
derived from a common lineage. How this diversity is introduced into the tissue through the actin cytoskeleton,
which supports the creation of different cell-specific shapes, is not yet well understood. To address this
question, here we will examine cytoskeletal regulation in the developing Drosophila pupal eye which has four
epithelial cell types that each acquire distinctive shapes and that we have recently found become characterized
by different F-actin structures, making it the ideal model. To elucidate how these cytoskeletal structures arise
and their specific role in distinct cell architectures, we will use genetic, live-imaging and immunofluorescence.
Our approach will establish which actin-regulatory genes are active in their formation and whether these
cytoskeletal structures are shaped by local position-dependent mechanical forces. Epithelial cells are linked to
each other via adhesive junctions and, especially as epithelia mature, these junctions are stabilized via
connections to the actin cytoskeleton. However, we recently discovered that in the fly pupal eye, F-actin is
unexpectedly removed from specific junctions providing the opportunity for us to decipher mechanisms that
orchestrate the reversal of junction stability. Our genetic dissection of this process will provide insight into how
actin is similarly removed from junctions in other tissues and disease states such as epithelial-to-mesenchymal
transition. Erosion of F-actin, as well as the earlier generation of actin structures in the eye, likely occurs
through genetic regulation, and so we will use single-nuclei RNA-seq to systematically map gene expression in
individual cell types of the Drosophila eye. Our work will generate a comprehensive and dynamic
understanding of gene expression crucial for morphogenesis of the cytoskeleton and its regulation in a
complex epithelial tissue. Here, we will also characterize gene expression related to other aspects of eye
development and maturity, revealing new regulators of tissue morphogenesis that will warrant future
investigation. Uncovering the genetic bases of development, and homeostasis, will also help accelerate future
development of therapeutic strategies to combat disease.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Our organs are characterized by collections of different cells that each have unique three-dimensional shapes that are important to the function of that cell and the tissue in which it resides. Often, when a cell functions incorrectly, it is because its shape has been disrupted. It is therefore critical that we understand how cell shape is established and maintained, so that we can understand the causes of cell disruption in disease and develop approaches to overcome these. This research will uncover which specific components of the cell (genes and proteins) function to generate differently shaped cells in a complex tissue. This better understanding is crucial for the development of advanced drugs to prevent or repair these cell disruptions, providing the opportunity to combat diseases that currently do not have any cure.